Experimental Pathology Laboratory (EPL)

The Experimental Pathology Laboratory (EPL) provides histopathology support across a large number of collaborators within the Centers for Cancer Research, as well as ongoing support to studies that include investigators in DCEG, NCI, as well as multi-institute collaborations between NCI and other NIH institutes. The EPL has provided a diversity of services, including tissue microarray (TMA) construction, development and deployment of immunohistochemical assays, tissue fixation, processing, embedding and microtomy, as well as whole slide imaging. Additional support included in situ assays for RNA and DNA, digital droplet PCR and image analysis. Sectioning and staining of frozen tissue is offered, and pathology interpretation of results, including scoring of immunohistochemical stains are provided. Over the last reporting period, the laboratory has directly contributed to nine publications. The time frame from the support provided by the EPL can vary from months to over 5 years, as some projects are in the final phases, for which the EPL provides the critical last elements of data. Other projects are foundational, including the construction of TMAs for which extensive effort may be devoted in screening samples and construction of the TMA, for which publication of the effort may be 2 or more years later. However in many instances, these projects will continue to contribute value for over a decade. The outcome of task conducted in the EPL is diverse. Recent studies have included screening the expression patterns of potential cancer antigens, in support of new CAR-T and Antibody-based therapeutics. Other efforts include the confirmation of expression of potential biomarkers of cancer prognosis by immunohistochemistry. The detection of glycoproteins by means of immunohistrochemistry, in the context of cancer antigens or therapeutic targeting has become a critical portion of the EPLs contribution to CCR investigators. Evaluation of the relationships of immune-cell populations their regulatory interplay is carried out with immunohistochemistry and image analysis.